Effective Primary care practices that Enhance Recovery Trajectories after pneumonia (EXPERT)

Even before COVID-19, pneumonia with respiratory failure was a very common cause of hospitalization.
Unfortunately, many patients who survive pneumonia have persistent health problems for months or years
afterwards. The objective of this Effective Primary Care Practices that Enhance Recovery Trajectories
after Pneumonia (EXPERT) study is to use appreciative inquiry to help primary care clinicians take better care
of pneumonia patients in the 6 months after hospital–by taking a strengths-based approach for
transformational change to design and test a new systems-level intervention.
We will use a multi-methods approach wherein quantitative analysis of primary care actions and qualitative
interviews with expert primary care clinicians and patients are used to refine an innovative intervention in a
participatory prototyping pilot trial. The pilot trial targets mechanistic process outcomes linked to increased
hospital-free days for pneumonia survivors. Our team from primary care, hospitalist medicine, critical care,
palliative care, sepsis, informatics, clinical epidemiology, medical sociology, and clinical trials, will:
Aim 1: Quantitatively analyze granular EHR data to identify and refine candidate components for a
primary care intervention to improve post-pneumonia care. We will leverage large, feature-rich datasets
from our team’s 3 diverse health systems to identify specific orders, referrals, and billing services by primary
care clinicians that are substantially more frequent in the 6 months after pneumonia than before and temporally
associated with reduced subsequent hospitalization. Aim 2: Qualitatively analyze the experiential insights
of primary care clinicians and pneumonia survivors to identify and refine candidate components and
identify enablers and barriers for the post-pneumonia intervention. We will conduct semi-structured
interviews and focus groups with PCCs and pneumonia survivors across 4 states to evaluate key actions and
implementation factors for successful post-pneumonia recovery. Aim 3. Refine and pilot a novel
multicomponent primary care intervention to improve delivery of post-pneumonia care that will lead to
improved health outcomes for pneumonia survivors. We will use a novel stakeholder-engaged strategy of
participatory prototyping to iteratively optimize the intervention and evaluate its effects on target mechanistic
outcomes in an eight-site cluster randomized pilot trial design.
EXPERT’s research addresses a fundamental knowledge gap in post-pneumonia care, a public health priority.
We propose to use appreciative inquiry to help primary care do what primary care does well, and to optimize
an intervention that makes it easier for them to do so.

Public health relevance
Even before COVID-19, pneumonia with respiratory failure was a very common cause of hospitalization in the United States. Unfortunately, many patients who survive pneumonia have persistent health problems for months or years afterwards. The goal of this Effective Primary Care Practices that Enhance Recovery Trajectories after Pneumonia (EXPERT) study is to use appreciative inquiry to help primary care clinicians take better care of pneumonia patients–by taking a strengths-based approach for transformational change to design and test a new systems-level intervention.